ANIMAL RESOURCE FOR RETINOIDS

Furnish services, qualified personnel, and material, equipment, and facilities, not otherwise provided by the Governmentunder the terms of this contract as needed to provide the Laboratory of Chemoprevention, NCI, with an animal resource for evaluation of the chemopreventive activity of retinoids, natural and synthetic derivatives of vitamin A, and other related chemopreventive compounds in experimental models for cancer of the breast, urinary bladder, esophagus, lung, andother systems to be decided at the mutual agreement of the Project Officer and the Principal Investigator.